Innovative Training Experiences for Occ Med Residents in Non-urban & Ag Settings

Project Summary/Abstract
Non-urban populations are given little attention in many aspects of medical practice. Rural communities often
lack the infrastructure for developing and sustaining a preventive approach to occupational disease and injury,
particularly for specific work sectors such as agriculture, where the hired and/or migrant workforce may
constitute the majority. Northeast Texas, home to about 1.5 million people spanning 35 counties, is considered
the largest rurally distributed population in the state, and is also one of the unhealthiest. There is a
considerable need to train medical students and graduates in general, and occupational medicine residents in
particular, to be competent in knowledge and skills pertaining to rural and migrant populations, who have
special cultural needs and considerations.
As the region’s only university medical center, the University of Texas Health Science Center at Tyler
(UTHSCT) is home to some of the latest developments in patient care and community health, medical and
health education, and biomedical and clinical research. There is a physician shortage in rural counties
throughout Northeast Texas, and UTHSCT has the responsibility of training the future generation of physicians.
The occupational medicine residency program at Tyler (OMR) is one of seven ACGME-accredited graduate
medical education (GME) programs sponsored by the institution. The overall objective and mission of the
program is; ‘to increase the number of occupational medicine physicians who have adequate experience and
sufficient competence to enter the practice without direct supervision, while adding a special focus on training
in the occupational health needs of the rural workforce, to help serve the population of Northeast Texas and
beyond’. This is in alignment with the overall mission of the institution.
Specific aims of the program are to: 1. Increase the number of board certified occupational medicine graduates
able to engage in evidence based and independent practice in various settings including the proportion
remaining in Texas and rural areas, 2. Enhance a robust residency experience in rural / agricultural
occupational health, safety, protection and promotion.
There remains a recognized burden of occupational injury and illness in general and in agriculture specifically.
This proposal is considered responsive to the Funding Opportunity Announcement PAR-15-352 by addressing
a critical gap in Occupational Medicine Residency (OMR) trained physician workforce needs (core discipline).
The proposed program will integrate agricultural safety and health by implementing a multi-faceted training
approach that relies upon an inter-professional educational team effort, while also leveraging the strengths of
the NIOSH-supported Southwest Center for Agricultural Health, Injury Prevention and Education to achieve a
significant impact on continued workforce expansion.

Public health relevance
Project Narrative (Public Health Relevance) This Training Project Grant proposal is in keeping with the Centers for Disease Control and Prevention Healthy People 2020 (also with the new 2030 framework) and the NIOSH mandate to provide an adequate supply of qualified personnel to carry out the purposes of the Occupational Safety & Health Act. The main objectives are to: 1) seek support for sustaining and increasing the number of occupational medicine trained physicians who have broad experience and sufficient competence to enter practice without direct supervision, and 2) bring a dimension of training that emphasizes the occupational health needs of the rural workforce with special attention to agriculture. This will be accomplished through a multi-faceted approach including a didactic course of study, including the Agromedicine Workshop, exposure to outreach and research activities at the NIOSH Southwest Center for Agricultural Health, Injury Prevention and Education (SW Ag Center); a supervised practicum experience in collaboration with the Rural Family Medicine Residency Program in Pittsburg, TX and with the National Center for Farmworker Health (NCFH) and affiliated Migrant and Community Health Centers; and field experiences such as worksite “walkthroughs” at industrial, agricultural and rural job locations. .